CRDF Coordinating Center: Logistics Support Under CRDF Global

As part of its long-standing support for international research programs of the National Institutes of Health (NIH), CRDF Global will provide project coordination, financial management and logistical support services for the National Cancer Institute's (NCI), Division of Cancer Control and Population Science (DCCPS).